Self-Management and Resilience Trajectories in African American Adults with Hypertension

PROJECT SUMMARY/ABSTRACT:
Although substantial data are available on the treatment and management of hypertension (HTN), lifestyle
modification and medication adherence to antihypertensives therapy, self-managing HTN remains suboptimal
in African Americans (AA) and has major impacts on health outcomes and patient care cost with direct medical
expenditures estimated to cost $42.9 billion annually. Self-managing HTN to a blood pressure (BP) goal of
<130/80 mmHg presents challenges such as juggling multiple medications and health care providers, dealing
with complex recommendations and treatment regimens, and coping with negative emotional states.
Resilience can be an important factor that protects health, well-being, and quality of life in the context of self-
managing HTN. However, there has been a paucity of studies that have examined the biopsychosocial
mechanisms that foster effective HTN self-management and resilience among AA. Understanding the
mechanism that influence HTN self-management and resilience holds the promise of new modifiable targets
for behavior change interventions. This R21 application, Self-management and Resilience Trajectories in
African Americans with Hypertension, will explore the influence of resilience precursors on self-management
behaviors and on stress response, and the effects that these associations have on health outcomes (health-
related quality of life and BP) over a 6-month period. Our research is guided by the theoretical underpinnings of
both Glass and McAtee’s Society-Behavior-Biology Nexus of nested hierarchical influences on health and the
work of Szanton and Gill’s Society-to-Cell framework. Using a descriptive longitudinal cohort design, we will
recruit a convenient sample of 125 AA diagnosed with HTN with multiple chronic condition (MCCs).
Participants will be administered a battery of instruments to capture potential covariates, study variables, and
observe outcomes at baseline and months 3 and 6. The aims of this study are to [1] Assess the association
among resilience precursors (dispositional optimism and resilience, emotion regulation); stress response
(cortisol, interleukins, depression cognitions, perceived stress); HTN self-management behaviors and
capability (self-efficacy for chronic disease mangement, medication adherence to antihypertensives); and
health outcomes (HQROL, BP) among AA with HTN and MCCs at baseline and Months 3 and 6; [2] Determine
if stress response mediate the relationship between resilience precursors and health outcomes over time when
controlling for risk regulators; [3] Determine if self-management behaviors mediate the relationship between
resilience precursors and health outcomes over time when controlling for risk regulators; and [4] Identify
resilience trajectory patterns and factors that influence HTN self-management behaviors over time. This study
will advance self-mangement and resilience science through the identification and understanding of how
protective factors and resilience promote self-management behaviors and influence health at the individual
level and inform future interventional research intended to reduce CVD risks associated with suboptimal BP.

Public health relevance
PROJECT NARRATIVE African-Americans (AA) have substantially higher rates of hypertension and the behavioral changes necessary to self-manage hypertension to achieve optimal blood pressure control (BP <130/80 mmHg) are likely to be overwhelming, stressful, and challenging. Resilience can be an important factor that protects health, well-being, and quality of life in the context of self-managing hypertension; yet, the impact of resilience on hypertension self- management behaviors and how such behaviors may change over time (i.e., trajectories) is understudied. The proposed project will explore how protective factors and resilience promote self-management behaviors and influence health at the individual level, as well as identify ways to bolster resilience that can target interventions that may enhance the sustainability of self-management practices in AA with hypertension.